INDISPENSABLE AMINO ACID REQUIREMENTS IN ADULTS

To validate the original work done by W.C. Rose, including using stable isotope markers to compare and contrast his amino acid requirements that were based on nitrogen balance data.